Cancer Outcomes among Michigan Residents Exposed to Polybrominated Biphenyls

PROJECT SUMMARY
In 1973, an industrial accident resulted in the shipping of a brominated flame-retardant chemical instead of a
nutritional supplement to farms across Michigan. The mix-up led to the widespread contamination of the
Michigan food supply, exposing an estimated nine million Michiganders to polybrominated biphenyl (PBB). In
response to the disaster, the Michigan Department of Health and Human Services (MDHHS) created the
Michigan Long-term PBB Registry. The study was created to examine the adverse health effects associated
with exposure to PBB. One of the primary concerns of the exposed community was whether exposure to PBB
would increase their risk of cancer. Fifty years after the PBB disaster, the affected community still does not
have an acceptable answer to this question; although, preliminary evidence points to an increased risk of
several cancer types. Dr. Michele Marcus and her team at Emory University have formed a strong academic-
community partnership which now seeks to provide the affected community with some answers regarding their
cancer risk. The Michigan PBB Registry includes over 7,500 ever-active participants and now includes children
and grandchildren of those who ate the contaminated food. The PBB disaster provides a unique opportunity for
scientific inquiry, while also addressing a pressing community concern. Since PBB had a defined exposure
window, there is a possibility to study the harmful effects of an endocrine disrupting chemical during specific
lifestages (i.e. adulthood, childhood, in utero). Additionally, while PBB is no longer produced in the United
States (US), it has a similar chemical structure to other commonly used brominated flame retardants and
shares many concerning properties with other contemporary chemicals (i.e. lipophilic, long half-life, resistant to
environmental degradation). Our study seeks to understand the potential association between serum PBB
levels and cancer incidence and mortality. We have linked the Michigan PBB Registry to the National Death
Index to obtain mortality data and are in the process of linking to two state cancer registries to obtain cancer
incidence and mortality data. We will utilize standardized incidence and mortality ratios to first understand if
there is a higher burden of cancer in the Michigan PBB Registry compared to the general US population. Next,
we will utilize longitudinal and survival models to examine the association between serum PBB levels
(measured at several timepoints) and cancer incidence/mortality and time to these events, respectively. We will
also examine these models stratified by lifestage at exposure. Our proposal also includes a review of our
biorepository, that includes over 35,000 additional stored samples, to identify samples taken before and after
cancer diagnoses to set up future nested case-control studies to examine underlying biological mechanisms. It
is our hope that this study contributes not only to our understanding of the role of endocrine disrupting
chemicals in cancer but provides much needed information to the affected community which can utilize this
information to make informed healthcare decisions with their providers about cancer screening.

Public health relevance
PROJECT NARRATIVE Since an industrial disaster in 1973 introduced a brominated flame retardant, polybrominated biphenyl (PBB), into the Michigan food supply, questions about PBB’s carcinogenic potential have been asked without a good answer. Our study examines the association between PBB and cancer incidence and mortality to provide an answer to the affected community and to act as a model for other endocrine disrupting chemicals still in use today. Our study will also prepare our biorepository for future nested case-control studies investigating the underlying mechanisms of cancer.